LEAD AND OTHER NEUROTOXINS AS RISK FACTORS FOR AMYOTROPHIC LATERAL SCLEROSIS

Exposure to environmental neurotoxins is likely to increase the risk of developing neurodegenerative diseases, either directly or through interaction with genetic susceptibility factors. Work has begun to asses the role of environmental exposures in the etiology of these disorders. ALS is a progressive neurological disease affecting motor neurons; its etiology is essentially unknown. A protocol has been developed for a case- control study of the role of environment risk factors in the etiology of ALS. The primary hypothesis is that cumulative lifetime exposure to lead is a risk factor for ALS. Lead exposure will be assessed by measuring bone lead, using the newly developed technology of x-ray fluorescence. Other environmental risk factors which will be investigated include aluminum, mercury, solvents, and pesticides. Biochemical variables reflecting suspected pathogenic mechanisms will also be measured, and their interactions with exposure to lead and other neurotoxins evaluated. The study will involve interviews and clinical and laboratory assessments for 200 incident ALS patients, 200 clinical controls, and 200 population controls.